Mathematical Modeling and Scientific Computing for Infectious Disease Research

Project Summary/Abstract
Emerging and reemerging infectious diseases represent a tremendous health and economic burden
throughout the world. The COVID-19 pandemic underscores the gap between the complex mechanisms
of disease transmission and spread and our current knowledge and intervention strategies. Several critical
issues such as the emergence of new variants, the consequence of vaccine hesitancy, the presence of
environmental transmission, the impact of underlying health conditions and behaviors, and the prediction
of disease spread, which are related to COVID-19 and applicable to a wide variety of infectious diseases,
are only partially and inadequately addressed at present. Mathematical and computational studies can
provide key insights into these challenges and improve our understanding of disease transmission, spread,
and progression. The overall objective of this proposal is to establish a new mathematical and
computational modeling framework for infectious diseases, with a focus on COVID-19, that integrates novel
mathematical modeling, extensive numerical simulation, and rigorous data validation. To achieve this
objective, we will pursue three Specific Aims: (1) Modeling the transmission dynamics of infectious
diseases; (2) Modeling the impact of underlying health conditions; and (3) Modeling the spatial spread of
infectious diseases. The proposed research is significant because it is expected to substantially advance
our current understanding of the complex dynamics associated with COVID-19 and many other infectious
diseases, which will potentially improve our current practice in disease control and outbreak management.
The approach is innovative in the development of novel mathematical models and advanced computational
techniques to address pressing needs for infectious disease research, in the integration of mathematical,
computational, and epidemiological methods, and in the involvement of undergraduate students for
authentic research through a progressive learning process. The project represents an interdisciplinary
collaboration between an applied and computational mathematician and a public health scientist who have
worked with each other for several years. A cohort of 5 undergraduate students per year, for a total of 15
over three years, will be supported by the project. The success of this project will build a solid knowledge
base for the complex dynamics of infectious diseases, will provide important guidelines for the public health
administrations in disease management and policy development, and will create a novel platform for
engaging undergraduate researchers and strengthening the institutional research environment.

Public health relevance
Project Narrative The proposed project has relevance for public health through a deep understanding of the mechanisms involved in the transmission, spread, and progression of infectious diseases. Such understanding, based on the mathematical and computational models developed in this project, will help inform outbreak responses and improve the current practice in epidemic/pandemic prevention and intervention. This research effort supports the NIH’s mission to reduce the public health burden of infectious diseases.